Health and Biomedical Science for a Diverse Community, *

[unreadable] DESCRIPTION (provided by applicant): [unreadable] Children's Hospital Oakland Research Institute (CHORI), in collaboration with the Hall of Health, a hands-on health museum, proposes a three-year Phase I SEPA project entitled "Health and Biomedical Science for a Diverse Community." The project entails development of a novel, interactive biomedical science curriculum for 4th and 5th grade students in low socioeconomic environments. Complementary to the curriculum, a hands-on exhibit on social and genetic factors in health will be developed to enhance learning by students and families. The curriculum and exhibit will be pilot tested with students from two elementary schools in Oakland, California. The curriculum--which will specifically address minority health issues such as asthma, obesity, diabetes, and heart disease--will include four five-lesson instructional units for 4th grade, and four five-lesson instructional units for 5th grade. In addition to classroom activities, the project will include workshops for teachers, family health and biomedical science nights, field trips to the Hall of Health, and an annual health and biomedical science festival for families. The project will involve clinical as well as basic science investigators, patients and families, and high school and college students. It will draw on the talents of teachers and health educators from the Oakland Unified School District, directors of SEPA projects at the Exploratorium in San Francisco and Lawrence Hall of Science in Berkeley, faculty at San Francisco State University and the University of California at Berkeley, and employees of LeapFrog, Inc., a company located in Emeryville, California, that makes interactive educational products. The ultimate goals of the project are to make science interesting and relevant to children who come from ethnically diverse, low socio-economic environments, to help them and their parents understand the relationship between science and health, and to foster their interest in science so that they may consider future opportunities in careers related to biomedical science. All project activities will undergo front-end, formative, and summative evaluation. [unreadable] [unreadable]